GM/CA@APS: A Macromolecular Crystallography Resource

The GM/CA@APS Resource provides user access to cutting-edge technologies for macromolecular
crystallography at two insertion-device beamlines (23-ID-B and 23-ID-D) at the Advanced Photon Source
(APS), Argonne National Laboratory (ANL). A major upgrade of beamline optics, endstations, computing
resources, motion control, and data acquisition systems will be completed during the current funding
period, simultaneously with an upgrade of the APS source. The new GM/CA optics provide an intense,
micro-focused beam (1-50 microns) more than 1000-fold brighter than before the upgrades, with
exceptionally stable position and intensity, over a wide energy range (5.0-35 keV,  = 2.48-0.35 Å),
Precision goniometry and fast, low-noise detectors (Eiger X 16M and CdTe Eiger2 XE 16M) will enable
users to take full advantage of the transformative new beamline capabilities. The GM/CA Macromolecular
Crystallography Core provides a modern, powerful environment with sophisticated tools for sample
screening, evaluation, data collection, and data analysis. Users will easily tailor the brilliant beam
properties to match their scientific needs, making GM/CA an ideal facility for microcrystallography that is
eminently suited for collecting data from weakly diffracting microcrystals. Cryo-protected samples are
robotically mounted from a 288-sample Dewar and can be visualized and manipulated in the beam. Users
control the beamlines and samples with the intuitive and biologist-friendly PyBluIce graphical user
interface that includes functions for beamline control, sample centering, screening, data collection,
energy scan, raster scan, and data analysis. The powerful raster scan feature can identify micro-crystals
or find the best diffracting region of a larger crystal for automatic data collection. Data collection is
automatically coupled to data processing pipelines, providing users with feedback in near real time. A
serial crystallography capability is implemented and integrated into PyBluIce for automated collection
from viscous injector and fixed-target delivery technologies. A computing cluster and storage array
network provide high-speed data storage, retrieval, backup, and real time data processing. With the
massively brighter new beam, most structures will be determined with multi-crystal datasets assembled
from many small wedges of data or from serial crystallography. The expert staff will prepare the user
community for the opportunities and challenges of the new APS through user workshops and new training
materials for both remote and on-site users. Staff also contribute to a variety of community outreach
activities including the annual CCP4/APS Crystallography School. GM/CA is led by Robert Fischetti (ANL,
contact PI) and Janet Smith (U Michigan, PI). A proactive maintenance plan ensures the high level of
performance and minimizes down time. During the 2020-2023 period, 624 unique individuals from 132
unique groups used GM/CA beamlines, deposited 225 structures in the PDB, and published 130 papers.

Public health relevance
GM/CA@APS is a national user facility that provides cutting-edge technologies for visualizing the 3D structures of protein and DNA molecules in atomic detail. Knowledge of 3D structures is essential to understanding how proteins and DNA perform their normal functions in living systems, how mutations in some proteins cause cancer progression, how drugs bind to their target proteins, how receptor proteins respond to external stimuli and transmit information from outside to inside the cell, how pathogens evade detection by our immune system, and how our proteins detect infection by pathogens. At the facility, an extremely intense, micro-focused X-ray beam is scattered from proteins packed in a crystal. The X-ray scattering may be recorded from a single crystal or many small crystals and used to determine 3D structures by the method of X-ray crystallography. Located at the Advanced Photon Source, Argonne National Laboratory, GM/CA provides the sophisticated instrumentation and highly automated software necessary for recording and analyzing the scattering data used in 3D structure determination.